Screening Lung Cancer by Ultra Low-Dose Computed Tomography

Principal Investigators/Program Directors (Last, First, Middle): Liang, Jerome Z. Project Summary/Abstract According to American Cancer Society statistics, lung cancer is the leading cause of cancer-related death in the United States, 212,380 of new cases diagnosed and 160,390 deaths in 2007. Early detection of lung cancers (less than 3 cm) can achieve a 90% ten-year survival rate. Early sign of the cancer is small lung nodules. Current screening of the lung nodules is performed by high-resolution computed tomography (CT), which carries a significant radiation and could increase the risk of getting cancer by as high as 2% according to a recent report in The New England Journal of Medicine. In addition to the screening, more CT scans are performed for follow-up and/or biopsy procedures. Reducing the radiation risk has been attempted by CT manufacturers by both hardware optimization and software enhancement. We have been exploring adaptive noise-treatment strategies to reconstruct similar image quality at significantly low mAs level for ultra low-dose CT applications on currently available hardware configuration. Iterative image reconstruction under a statistical cost function is one of the strategies which needs powerful computing engine (costs more than a half million dollars). Analytical image reconstruction after data restoration by a statistical cost function is another strategy which generates similar results as the iterative means with a dramatic reduction of computing burden. Our pilot studies by both phantom and volunteer experiments have demonstrated great potential of the latter restoration strategy for radiation reduction while retaining the image quality and reconstruction speed on currently available CT scanners. The proposed specific aims to further explore the potential for screening lung nodules are: (SA-1). To further investigate the adaptive noise-treatment strategies toward as low mAs as achievable for lung screening: Because the first and second moments of low-mAs CT data contain the essential statistical information about the noise (higher order moments have less impact on noise reduction), we will study the properties of sample mean and variance of the data as mAs level goes down as low as achievable. In addition, data correlations in the three-dimensional spatial domain associated with tomographic imaging will be investigated. Both the noise properties and data correlation will be incorporated into a statistical cost function, i.e., Kharhunen-Loève domain penalized weighted least-squares, which can be efficiently minimized for data restoration by an analytical fashion at the highest speed. Image reconstruction from the restored data will also be analytical at the highest speed. For comparison purpose, iterative image reconstruction under a similar statistical cost function will be refined. (SA-2). To evaluate the investigated adaptive strategies by the detection of small lung nodules: The presented strategies will be first evaluated by repeated experiments on anthropomorphic phantoms with variable low mAs protocols using noise-resolution tradeoff measure and receiver operating characteristics (ROC) and channelized Hotelling trace (CHT) observer studies. Then the evaluation will be on patient lung nodule detection with comparison to currently-used mAs level by a same CT scanner, where quantitative measures will be made using performance equivalence tests and ROC studies. The successfully evaluated strategies may lead to a large clinical trial for ultra low-dose CT screening of the lung nodules, and could be extended to screening of other vital organs, such as the colon, heart, and breasts. PHS 398 (Rev. 04/06) Page __1___ Continuation Format Page

Public health relevance
Project Narrative Current practice of computed tomography (CT) in clinic frequently delivers excessive X-ray radiation to the patients by using a higher mAs scanning protocol than needed. This causes a major concern when screening is the clinical task, e.g., screening lung cancer. If the mAs value is lowered, image noise will increase and streak artifacts may present (because there is no effective noise treatment in current CT scanners), compromising the clinical assessment. This proposal aims to reduce the X-ray exposure risk by lowering the mAs value as low as achievable, while retaining the image quality suitable to the clinical task. The key technical component is a software module which can be easily adapted by current clinical CT scanners without any hardware modification except for a few seconds of computing time. The module reads in CT data, analyzes and then treats the data noise prior to reconstructing the data, preventing image noise and artifact. PHS 398 (Rev. 04/06) Page __1___ Continuation Format Page __SpecificAimsTextDelimiter__ Principal Investigators/Program Directors (Last, First, Middle): Liang, Jerome Z. a. Specific Aims This proposal aims to reduce the radiation risk associated with current clinical practice in lung cancer screening and follow-ups using computed tomography (CT). At the screening stage, a high electric current across the X-ray tube, reflected by a high mAs value, of greater than 100 is used, resulting in a so called standard or full-dose scan. For follow-ups (including biopsy purpose), the mAs value can be reduced to 50, called low-dose scan. Attempts have been made to apply low-dose scan for screening purpose, but the detection task encountered challenges because of increased noise in the reconstructed images, resulting in missing detection of nodules. Attempts have also been made to reduce the mAs value below 50 for follow-ups, but the presence of streak artifacts in the reconstructed images causes (i) quantitative measuring errors on the nodule volume changes [111] and (ii) distraction on the visualization of the images. In the past decade, we have been investigating adaptive noise-treatment software strategies to reconstruct similar image quality at significantly lower mAs level for ultra low-dose CT applications on currently available CT hardware configuration [55-57, 70, 77, 78, 80, 114-122]. A noticeable progress has been made based on our accumulated expertise and extensive experience in developing statistical image reconstruction in Nuclear Medicine, e.g., in single photon emission computed tomography (SPECT) [9, 10, 26, 52, 54, 58, 59, 61, 67, 72-76, 128] and positron emission tomography (PET) [68]. We recognize that iterative image reconstruction under an optimization of a statistical cost function, e.g., Bayesian inference, maximum a posteriori (MAP) or penalized maximum likelihood (pML) [62-66], is a choice, where the likelihood in the cost function models the data statistical property and an a priori probability term imposes a constraint or regularization on the image intensity distribution via a local spatial correlation among image voxels [23]. There are many advantages associated with the statistical iterative image reconstruction compared to traditional analytical image reconstruction, which inverses the data for the solution non-iteratively and ignores the data statistics and correlations. However, the iterative reconstruction also has drawbacks. One drawback is intensive computation for several iterations of re-projection and back-projection cycles. The computation becomes more intensive as data and image sizes increase. We have been exploring ways to relieve the computing burden by avoiding the re-projection and back-projection cycles while retaining the advantages of modeling the noise and local correlation in our late researches on SPECT [58, 59, 79] and PET [68], and recently on low-dose CT (LDCT) [57, 116-118]. The central theme is to restore the data under a statistical cost function so that the restored data is an optimal observation of the source, and the restored data and associated source are governed by a mathematical relation which can be analytically resolved without the re-projection and back-projection cycles. Our pilot studies by both phantom and volunteer experiments have demonstrated great potential of the statistical restoration strategy for radiation reduction while retaining the image quality and reconstruction speed on currently available CT scanners [116-118]. The long-term objective of this project is to establish ultra (or super) LDCT modality through cost-effective means of modeling data statistics and correlations, based on modern CT hardware configuration. The goal of this proposal is (1) to further investigate the novel statistical restoration strategy which was tested in several pilot studies with very encouraging results on currently available multi-slice CT systems, and (2) to evaluate the strategy for lung nodule screening. The specific aims to achieve the goal are detailed as follows: (a.1). (SA-1) To further investigate the adaptive noise-treatment strategies toward as low mAs as achievable for a clinical task (e.g., lung screening) We emphasize adaptive-ness because the traditional analytical image reconstruction does not effectively consider or adapt the data statistics and correlation and, therefore, can not produce high quality images when data contain significant noise at low mAs level. For CT imaging, the data statistics is described by a compound Poisson process plus a background noise of normal distribution [48, 125-127]. Despite its complex in numerical implementation, the essential information of the data statistics can be described by the first and second moments (higher order moments have less impact on noise reduction). Therefore, we will investigate the properties of data sample mean and variance as mAs level goes down as low as achievable. PHS 398 (Rev. 04/06) Page __1___ Continuation Format Page Principal Investigators/Program Directors (Last, First, Middle): Liang, Jerome Z. In addition to the data statistics, data correlations in the three-dimensional (3D) spatial domain associated with tomographic imaging are also very useful for noise reduction. Unfortunately, this has not been widely recognized, because nearly all previous statistical iterative reconstructions impose a penalty among the nearby image voxels rather than directly modeling or adapting the data correlation property. To remedy this or explore the utility of the correlation, we will investigate the data correlations in the spatial domain for step- and-shoot and spiral scanning modes (both modes are widely used in clinic). Both the data statistics and data correlations will be incorporated into a statistical cost function, e.g., Kharhunen-Loève domain penalized weighted least-squares (KL-PWLS) framework, which can be efficiently minimized by an analytical fashion for the highest speed. For comparison purpose, iterative reconstruction under a similar statistical cost function will be refined for reference. (a.2). (SA-2) To evaluate the investigated adaptive strategies by the detection of small lung nodules: Evaluation is a necessary step toward establishment of a new technology [19, 26, 62a, 85]. We will evaluate the investigated adaptive noise-treatment strategies by multiple phantom simulations and experiments with mAs values in the range from 10 to 150, and kVp value of 100, 120 and 140 respectively. In simulation studies, anthropomorphic digital phantoms will be derived from patient CT images. In experimental studies, the anthropomorphic torso phantom (Radiology Support Devices, Inc., Long Beach, CA) and a 16-slice CT configuration will be used. The evaluation merits include image artifacts and noise-resolution tradeoff measures, as well as receiver operating characteristics (ROC) and channelized Hotelling trace (CHT) observer studies given the gold standard or the known phantom configuration, although other evaluation criteria could be employed [19, 58, 59, 62a, 85]. We expect that by effectively adapting the low-mAs CT data statistics and correlations in a mathematically or statistically rigorous noise-treatment framework, the noise-resolution tradeoff shall be optimized and the observer detectability shall be improved, as compared to the conventional filtered backprojection (FBP) reconstruction which uses spatially-invariant signal-independent low-pass filters to handle the spatially-variant, highly signal-dependent noise. This is a hypothesis to be tested. In addition to the above comparison with currently available noise filters [30], comparison to statistical iterative image reconstruction will also be performed. Since the iterative image reconstruction considers the similar statistical information as the KL-PWLS strategy does, we expect that their results would be similar, but the calculation of the KL-PWLS minimization shall be much more efficient and consistent than the iterative pML/MAP image reconstruction. This is because that the KL-PWLS has less freely-adjustable parameters and does not need any iteration for the re-projection and back-projection cycle through the image space. This is another hypothesis to be tested. Then the evaluation will be extended to patient lung nodule detection with comparison to currently-used mAs level on a same CT scanner. During a five-year period, we plan to recruit, at least, 325 subjects who will undergo lung biopsy on detected nodules of 5 mm and larger. More than 20% of such population has unreported small nodules of size smaller than 5 mm [27]. So we expect to obtain 75 positives (who have unreported small nodules) and 250 negatives. Each subject will have more than one CT scans for the biopsy purpose. At least one scan will be taken at the full-dose level, and the other at ultra low-dose level. We hypothesize that there will be no significant difference between the KL-PWLS reconstruction of the ultra low- dose scans and the conventional FBP reconstruction of full-dose scans for the detection of the unreported small nodules using performance equivalence tests and ROC measures. We also hypothesize that there will be no significant difference between the KL-PWLS and the statistical iterative reconstruction of the ultra low-dose scans on the detection task. The successfully evaluated strategies may lead to a large clinical trial for ultra (or super) LDCT screening of the lung cancer, as well as other vital organs, such as the colon, heart and breast. PHS 398 (Rev. 04/06) Page __2___ Continuation Format Page